Michigan Summer Undergraduate Research Experience: Diabetes & Metabolic Diseases

Abstract
To improve health and quality of life for people with diabetes and other endocrine and metabolic
disorders; liver and intestinal diseases; and obesity, there is tremendous need for well-trained
basic and clinical researchers who further our mechanistic understanding of the molecular and
cellular underpinnings, and who translate these findings to therapies. To that end, it is important
to encourage recruitment of talent from varied scientific disciplines to these research areas.
Programs linking talented undergraduate students with research training opportunities in both
foundational science and clinical research will help fuel interest in scientific research and spark
new careers to strengthen the scientific workforce for the decades to come. Thus, to promote
and retain a steady and diverse pool of new scientists, we propose the Michigan Summer
Undergraduate Research Experience: Diabetes & Metabolic Diseases (M-SURE). Our goal is to
provide a meaningful undergraduate student research and mentored experience to instill
appreciation and passion for discovery, and to propel trainees towards careers in biomedical
research. To achieve this goal we plan to 1) recruit fourteen undergraduate trainees per year for
a summer research experience with mentors from an outstanding pool of 23 faculty
investigators engaged in cutting-edge basic and clinical research in diabetes, endocrinology and
metabolic diseases, 2) establish a regional and national recruiting program for recruitment of
underrepresented minority trainees to enhance diversity of our M-SURE program and the
pipeline for future scientists working in diabetes, endocrinology and metabolic diseases, and 3).
enhance our trainees’ experience with a weekly lecture series highlighting the physiology of
diabetes, endocrinology, and metabolism, how to develop a career in biomedical research, and
the responsible conduct of research.

Public health relevance
Project Narrative The Michigan Summer Undergraduate Research Experience: Diabetes & Metabolic Diseases (M-SURE) program provides undergraduate trainees with a meaningful mentored research experience to instill appreciation and passion for discovery, and to propel students towards careers in biomedical research. Our trainees gain a deep understanding of the basic and clinical aspects of research on diabetes, endocrinology, and metabolic diseases through strong laboratory-based research experiences, excellent mentorship, and an academic environment with a focus on multidisciplinary and comprehensive research in these areas. M-SURE training combines immersion in specific research projects under the direction of experienced and accomplished researchers with formal education and participation in a variety of other research- related educational activities.